Research Training in Pediatric Emergency Medicine

Project Summary/Abstract
The Pediatric Emergency Medicine Research Training Program (PEMRTP), established in
2001, offers a unique and comprehensive training experience for MD and PhD biomedical
researchers focused on investigating acute illnesses and injuries in pediatric emergency
medicine (PEM). With millions of children visiting emergency departments (EDs) annually, the
need for evidence-based care and effective diagnostics and treatments is paramount. As
pediatric research enters a new paradigm driven by data-driven care, artificial intelligence,
genomics, and optimization of electronic health record systems, the PEMRTP aims to advance
the care of acutely ill and injured children by training independent researchers, with a strong
focus on informatics, genomics, and artificial intelligence. The COVID-19 pandemic also
highlighted the central role of pediatric EDs in children's healthcare, and as a critical link in
national public health surveillance programs. This competing renewal builds upon the assets of
Boston Children's Hospital, housing the largest PEM faculty worldwide, to create a culture of
rigorous research and training. The program's goals remain to prepare trainees for independent
research in PEM and address the critical need for research mentors in the field. The next
funding cycle plans to include 12 participating trainees. Trainees in the PEMRTP will progress
through four interrelated phases, including mentored research projects, ongoing didactic
instruction, formal coursework (optional), and preparation of a research grant. Additionally,
trainees have the opportunity to pursue formal coursework for advanced degrees such as
Master of Medical Science or Master of Public Health. Benefiting from the extensive research
laboratories, clinical systems, academic programs, experienced faculty, and connections to
multisite research networks at Boston Children's Hospital, the Computational Health Informatics
Program, and the Department of Biomedical Informatics at Harvard Medical School, the
PEMRTP provides an unparalleled environment for mentoring trainees to become future leaders
in pediatric emergency medicine research.

Public health relevance
Project Narrative In the United States, 19 to 25 million children make more than 29 million emergency department (ED) visits each year. The Pediatric Emergency Medicine Training Program offers unique training in biomedical informatics and genomics for the next generation of leaders in pediatric acute care research. Thus, when ill or injured children arrive at the ED, they can receive the best evidence-based care, with the most effective diagnostics and treatments possible.